Harnessing phage resistance mechanisms for optimization of antibiotic therapy in mycobacteria

ABSTRACT
Mycobacterium abscessus (MAB) is emerging as a clinically important pathogen associated with infections
in immunocompromised as well as healthy individuals. MAB incidents have been increasing worldwide leading
to high morbidity and fatality rates. While clinically available antibiotics effectively kill MAB in vitro, despite of
combinational and lengthy antimicrobial regimens, treatment outcomes in clinics are unpredictable and often
ineffective, demanding the use of novel therapies and technologies for improved results. Phage therapy is one of
the promising alternatives under development for Cystic Fibrosis patients that has been successfully used during
difficult to manage cases such as multidrug-resistant and disseminated infections of MAB. Moreover, phage-
antibiotic combination treatments have been shown to be more effective over the use of single agents. The current
use of therapeutic phages in humans is limited to lytic phages that can efficiently lyse and inhibit the growth of
the host bacteria. However, substantial research demonstrates that lytic phages can steer the evolution of phage
resistance in bacteria at a cost of increased vulnerability to antibiotics and immune system, diminishing bacterial
virulence in the mammalian host. The overall goal of this application is to deepen the fundamental understanding
of phage biology by elucidating the interaction mechanisms with mycobacteria and assessing the fitness costs
linked to the trade-offs between phage resistance and antibiotic resistance. This knowledge will be applied toward
the translational goal of this proposal for designing phage formulations that can synergize antibiotic action,
ultimately enhancing clinical outcomes. Therefore, in the Aim 1A, we will identify MAB surface targets involved
in distinct phage resistance mechanisms. Our central hypothesis is that bacterial surface factors contributing to
phage resistance can compromise the integrity of the mycomembrane and reduce the functionality of
mycobacterial surface targets involved in antibiotic intrinsic resistance. By finding phages that can drive diverse
pleiotropic effects, we aim to sensitize MAB to conventional antibiotics via phage-antibiotic combination therapy.
In the Aim 1B, we will validate trade-offs between phage and antibiotic resistance and evaluate increased efficacy
of antibiotics in drug-susceptible and drug-resistant MAB isolates through the use of phages. The new knowledge
gained from this proposal will directly inform the rational design of phage cocktails and phage-antibiotic
combinations, enhancing the clinical efficacy of current antimicrobials.

Public health relevance
NARRATIVE Mycobacterium abscessus causes significant pulmonary infections in individuals with cystic fibrosis and other chronic lung conditions. Therapeutic phages are promising alternatives for most difficult to treat bacterial infections. This proposal aims to identify mechanisms of phage- mycobacteria interaction that alter bacterial cell wall integrity and defenses against antibiotics and improve effectiveness of current antibiotics through phage-antibiotic combination therapy.